The investigation of paternal-effect lethal mutations in C. elegans

DNA topoisomerases are enzymes that play a crucial role in chromosome fidelity by disentangling topological problems that arise in double stranded DNA. This enzyme has primarily been studied in mitosis. However, one side effect of topoisomerase II inhibitors is both female and male infertility indicating that it also has functions in the meiotic cell cycle. The exact role that topoisomerase II plays during meiosis is unknown. Using a combination of classical genetics and cell biology, we found that top-2(it7ts) males produce dead embryos, even when fertilizing wild-type oocytes. Characterization of early embryonic events indicates that fertilization is successful and sperm components are transmitted to the embryo. However, sperm chromatin is not detected in these fertilized embryos. Examination of top-2(it7ts) spermatogenic germ lines reveals that the sperm DNA fails to segregate properly during the meiotic divisions. Chromatin bridges form during anaphase I and the chromatin is removed from developing spermatids creating anucleate sperm. These anucleate sperm are nonetheless capable of fertilization; early embryonic events appear normal but embryos arrest around the 200-cell stage. Type II DNA topoisomerases have well known roles in DNA replication and chromosome segregation in the mitotic cell cycle of yeast and bacteria. To determine if, similar to other organisms, C. elegans top-2 also plays a role in mitosis, we examined the proliferative zone of top-2(it7ts) males and hermaphrodites where germ cells undergo mitotic proliferation prior to entering meiosis. We found that hermaphrodite and male germ lines have enlarged mitotic germ cells (indicative of an S-phase arrest). In addition, a top-2 non-conditional deletion allele fails to proliferate a germ line. These two results suggest that top-2 has a mitotic function in the proliferative region of the germ line. Given the known enzymatic role of topoisomerase II in disentangling topological problems that arise in double-stranded DNA, we reasoned that TOP-2 might solve topological problems that arise during meiotic crossover recombination. top-2(it7ts) chromosome segregation defects observed during anaphase I are not due to residual entanglements incurred during meiotic DNA replication and are not a consequence of recombination defects. Finally, we tagged TOP-2 with a FLAG epitope by CRISPR/Cas9 gene editing (TOP-2::3XFLAG) to determine TOP-2 localization in the germ lines of hermaphrodites and males. We found that TOP-2 associates with chromosomes in meiotic prophase and that chromosome association is disrupted in the germ lines of top-2(it7ts) mutants. In the future, we aim to use TOP-2::3XFLAG to discover internal phosphorylation and SUMOylation sites: potential post-translational modifications required for TOP-2 regulation. We also are conducting a suppressor screen to identify mutants that restore viability and chromosome segregation to the top-2 mutant.